Health Literacy Research Conference

Project Abstract Paasche-Orlow, M: Health Literacy Research Conference The National Institutes of Health (NIH) has defined health literacy as the degree to which individuals have the capacity to obtain, process and understand basic health information and services needed to make appropriate health decisions. Unfortunately, fully 22% of US adults have only basic and an additional 14% have below basic health literacy. The relationship between limited literacy and adverse health outcomes has been well documented, and seminal reports about health literacy have been issued by the Institute of Medicine, Agency for Healthcare Research and Quality, American Medical Association, and Joint Commission on the Accreditation of Hospital Organizations among others. Each of these reports advocates further research to develop an effective response and research in health literacy has begun to flourish. An important step to cultivate this emerging research field is to establish a national professional interdisciplinary home for investigators dedicated to health literacy research. We have set the stage with several successful meetings. In this grant application we propose to expand on our prior work to deliver a series of three annual conferences along a multi-year trajectory dedicated to the promotion of the field of health literacy research. These meetings will be designed to provide a venue to focus attention on health literacy research, emphasizing the role of health literacy research in topics such as patient safety, effectiveness of interventions, quality, prevention and care management, and information technology. The meeting will serve as an incubator for young investigators and will encourage a cross-disciplinary exchange of knowledge, collaboration, and creativity. We aim to create an environment in which controversial topics within the research community can be openly discussed. Dr. Paasche-Orlow has served as a guest editor for special journal issues emerging from each of the past meetings; we plan to continue our successful dissemination efforts with additional special issues on Health Literacy. We also plan to improve the meeting's Web site so that it can serve as a public resource for sharing information about health literacy measurement instruments.

Public health relevance
Project Narrative: Paasche-Orlow, M: Health Literacy Research Conference The relationship between limited health literacy and adverse health outcomes has been well documented. An important step to cultivate this emerging field is to establish a national interdisciplinary home for investigators dedicated to health literacy research. In this application we propose to expand on prior success with a series of three annual conferences dedicated to promoting the field of health literacy research with a focus on the role of health literacy in topics such as patient safety, effectiveness of interventions, quality, prevention and care management, and information technology.